Role of lymphatic endothelial cell NFkB signaling in adult lymph node homeostasis

PROJECT SUMMARY/ABSTRACT
The proposed study is significant because we aim to understand the cellular mechanisms that regulate
lymph node (LN) maintenance in aging. Aging causes LN atrophy and fibrosis and is associated with impaired
immune responses. However, although the morphological changes that occur in aged LNs have been well
studied, the molecular mechanisms that cause these changes are poorly understood. This gap in knowledge
is important because LNs play a key role in orchestrating immune responses. Therefore, our studies will help
uncover therapies that may improve immune function in elderly men and women.
Lymphatic endothelial cells (LECs) are the building blocks of the lymphatic system and, as a network of
lymphatic vessels, transport of interstitial fluid and antigens to regional LNs. LECs are also a component of the
LN stroma and regulate LN organogenesis during development and LN hypertrophy in response to inflammatory
conditions. These regulatory pathways are coordinated by canonical and non-canonical nuclear factor kappa-
light-chain-enhancer of activated B cells (NFkB) signaling in LECs.
Aging is known to impair lymphatic function and transport of interstitial fluid/antigens to the LN, and we
have shown in preliminary studies that LN LEC heterogeneity is altered in aged LNs and the expression of NFkB
by LN stromal LEC is decreased in aging animals. We also have found that deleting canonical NFkB-Rel-A
signaling in LECRel-A-/- mice results in significant LN atrophy and cellularity that is a phenocopy of the aging LN.
Based on this rationale, our central hypothesis is that decreased lymphatic function in aging results in
diminished expression of NFkB by LN stromal LECs, impaired production of lymphocyte survival signals, and
aging-related LN atrophy.
Our study is innovative because we plan to conduct single-cell RNA sequencing analysis of LN stromal
LECs, and we have developed inducible transgenic Cre-lox mice in which we can selectively decrease LEC
NFκB signaling in adult animals. This model system enables us to directly study the role of LEC NFκB expression
in LN maintenance and atrophy. These transgenic mice, combined with our LN transplantation, and in vitro 3D
models, will also enable us to selectively analyze changes in LN LEC NFκB signaling and understand how these
populations contribute to adult LN homeostasis using two Specific Aims: (1) Determine the effects of aging on
LN LECs and effect of lymphatic flow on LEC NFkB expression and (2) determine how LEC NFκB
signaling regulates LN homeostasis in adult mice.
At the conclusion of the proposed study, we expect to understand the cellular mechanisms that contribute
to aging-related LN atrophy and adult LN homeostasis. This understanding will provide the basis for future
studies designed to prevent or reverse aging-related LN atrophy.

Public health relevance
PROJECT NARRATIVE/RELEVANCE Aging-induced changes in the structure and function of lymph nodes result in lymph node atrophy, which is important because lymph nodes play a key role in orchestrating immune responses. The molecular mechanisms driving these changes in aging lymph nodes are poorly understood, but reduced activation of NFκB signaling in lymph node lymphatic endothelial cells may provide a rationale. Therefore, the information gained from the proposed study may help uncover therapeutic strategies that may improve immune function in the elderly and reduce their risk for autoimmune disorders, life-threatening infections, and impaired response to vaccines and tumors.